Data-driven Diagnostics using Multimodal- AI Assisted Approaches for Early Cancer Detection

Project Summary:
The vast majority (90%) of cancers are epithelial in nature, and oral squamous cell carcinoma (OSCC) accounts
for a portion of these cases by afflicting 744,884 people yearly, worldwide. Late-stage cancer diagnosis is
associated with low survival rates, whereas individuals diagnosed at an early stage have a significantly better
chance of survival. Current standard screening examinations often fail to identify abnormal regions with high risk
of malignancy, and, thus, need to be improved to increase survival rate. Dr. Gracie Vargas, my sponsor, has
developed a detection approach that combines multiple optical imaging modalities to visualize large areas
(widefield, WF) with complementary microscopic areas (nonlinear optical microscopy, NLOM) for label-free
identification of neoplasia. This approach has demonstrated substantial image-based alterations in high-risk
lesions using the system in preclinical animal models. As with many novel optical systems, our research shows
there is room for optimization in this promising technique. The handling and evaluating of the complex data and
identifying the most important features associated with early cancer changes is an additional challenge,
particularly in the application in human specimens. Here, I propose an approach that combines label-free
multimodal optical imaging with artificial intelligence (AI) to develop data-driven diagnostics for detection of early
high-risk lesions with potential for malignant, to ultimately increase survival rate. In the F99 phase, I will optimize
and evaluate a WF system by integrating a seamless spectral capability, to capture a wide range of spectral
features in human OSCC samples. This optimization will acquire additional image-based information that applied
to machine learning methods to extract the most important features associated with early cancer changes, while
potentially improving the systems performance. My dissertation work during the F99 phase will equip me with
training and expertise in the integration of biomedical optics, under the guidance of Dr. Gracie Vargas at the
University of Texas medical Branch at Galveston, and machine learning, with support from my co-sponsor, Dr.
Heidi Spratt, to advance translational early cancer detection. In the postdoctoral K00 phase, I will concentrate
on developing multimodal label-free optical approaches for data-driven early cancer diagnostics. This research
involves complex decision-making that can extend beyond the capabilities of traditional machine learning. Thus,
as I transition to the post-doctoral phase, I will train in advanced AI methods, such as deep learning, as well as
explore the integration of patient records to enhance early cancer diagnostics. The successful completion of this
project will advance emerging noninvasive early cancer multimodal microscopy technologies through cutting
edge data-driven approaches, ultimately enhancing early epithelial cancer detection and diagnostics.

Public health relevance
Project Narrative: Early cancer diagnostics is critical because the number of cases is rising, and the chances of survival increase if caught at an early stage. Currently standard screening examinations often fail to detect these initial changes, and their challenge is to identify abnormal areas with a high likelihood of cancer transformation. In this project, we will develop a new approach for detection that uses large and small imaging with guidance of artificial intelligence methods for consistency in early cancer diagnostics.